Clostridioides difficile Zinc-binding PBPs as anti-sporulation targets

Abstract
Clostridioides difficile is the leading cause of nosocomial infection. The use of b-lactam antibiotics, especially
cephalosporins, is a major risk factor for infection, but high dietary zinc concentrations have also been shown to
increase infection rates. Current treatments of C. difficile infection (CDI) are plagued by high recurrence
frequency due to C. difficile spores, which are the main vehicle of transmission and highly resilient against harsh
environmental conditions. We hypothesize that penicillin-binding proteins (PBPs), the target of b-lactam
antibiotics, may play important roles in C. difficile cephalosporin resistance while serving as valuable targets for
novel antibiotic development, especially targeting C. difficile sporulation in recurrent infection. Despite PBP’s
biological and clinical importance, our understanding of PBPs has mostly relied on studies of a few model
organisms. Most recently, we have demonstrated, for the first time, that the structures of several C. difficile PBPs
contain a zinc ion in their active site, a feature never observed in PBPs from model organisms but likely prevalent
in other bacteria. We have also developed a series of diazabicyclooctane (DBO) compounds as potent anti-
sporulation reagents by inhibiting PBP3, a PBP critical for sporulation. Here we propose to 1) elucidate the roles
of PBPs and other peptidoglycan transpeptidases in the pathogen’s complex life cycle and determine the b-
lactam resistance profile through biochemical/structural analysis and gene knockout/knockdown experiments; 2)
apply a structure-based design approach to develop new PBP inhibitors targeting C. difficile sporulation. Taken
together, the proposed studies will deepen our understanding of PBPs across bacterial species and provide new
knowledge about the unique properties of C. difficile PBPs, particularly those related to the risk factors of CDI
and future drug discovery to address current treatment challenges. The results will also facilitate the development
of new combination therapies for recurrent CDI by using existing CDI drugs such as vancomycin and anti-
sporulation inhibitors.

Public health relevance
Clostridioides difficile is the leading cause of nosocomial infection and is classified as ‘urgent threat’ by the Centers for Disease Control and Prevention (CDC). This proposal investigates the structure, function and inhibition of C. difficile cell wall transpeptidases essential for its vegetative growth and particularly, spore production. The results will offer valuable information for understanding C. difficile antibiotic resistance, and provide new chemical matter for developing novel anti-sporulation compounds against C. difficile infection.